VASCULAR AND METABOLIC EFFECTS IN THE TREATMENT OF TYPE II DIABETES

This protocol will determine the effect of dietary intervention on forearm vascular reactivity, plasma insulin and glucose, plasma leptin, serum fucose, plasma IGF-I level, in vitro platelet function, insulin and glucose sensitivity, percent body fat, waist to hip ratio, and cholesterol, in subjects with type II diabetes mellitus.